Direct and Quantitative Probing of Desmosome Mechanotransduction

PROJECT SUMMARY
Intercellular adhesive junctions, including desmosomes and adherens junctions, connect epithelial cells within a
tissue to provide mechanical integrity, regulate cell sorting and migration, and control chemical signals that
further instruct cell decisions. In particular, desmosomes resist mechanical stress and respond to mechanical
cues to regulate complex cell behaviors to promote differentiation, facilitate migration and wound healing, and
mediate other functions critical in development and in diseases of many tissues, including the skin and heart.
While significant progress has been made identifying potential load-bearing elements within desmosomes, a
huge knowledge gap exists about their roles in epithelial mechanics and mechanotransduction. Specifically, the
mechanisms of force regulation across the desmosome-intermediate filament linkage are poorly understood.
There is limited direct evidence for when and even whether the molecular components of desmosomes bear
mechanical loads, the first step towards mechanotransduction. More importantly, still unaddressed is whether
specific desmosome components act as mechanosensors that determine the strength and duration of chemical
signaling pathways critical in adapting to mechanical stresses in tissues. Our previous studies showed the
capacity of desmosome-intermediate filament linkage in regulating cell mechanics, a role that has long been
regarded to belong solely to adherens junctions. This suggests the potential for desmosomal components to
participate in force regulation. In this MIRA project, building on these findings and leveraging a newly developed
single cell-cell adhesion interrogation platform, we will examine the important, but less studied, role that
desmosomes play in epithelial mechanics and in mechanotransduction. We will focus on two major research
thrust areas: 1) investigate the role desmosome plays in maintaining the mechanical integrity of epithelial cell-
cell junctions and 2) determine its potential in transducing mechanical cues at the junction in coordination with
mechanosensitive molecules at the adherens junctions and the actin network. Through a series of studies on
epithelial cells with desmosomal components harboring loss- and gain-of-function mutations, we will quantify the
contribution from each desmosomal protein in maintaining epithelial mechanical integrity in stressed conditions.
We will answer the question: How does actin-based contractility affect desmosome regulation of tension within
actin-based adhesive networks? We anticipate providing the first direct observation of desmosome serving as a
mechanotransduction site at the cell-cell junction. The proposed studies will enhance our understanding of how
desmosomes coordinate chemical and transcriptional pathways in response to mechanical tension in the
epithelia, lay the groundwork for similar studies of desmosome mechanosensing in other tissues, and ultimately
provide new knowledge to aid in developing treatments for disorders resulting from interference with these
adhesive junctions and their mechanosensing pathways.

Public health relevance
PROJECT NARRATIVE Desmosomes are critically important in resisting mechanical stress, impacting tissue morphogenesis and human health, but much is unknown about its role in the mechanics and mechanotransduction at the epithelial cell-cell junction. Through this program, we will examine the desmosome’s ability to maintain the mechanical integrity of the junction and determine its potential to transduce mechanical cues at the junction in coordination with molecules at the adherens junctions and the actin network. The understanding will aid in developing treatments for disorders resulting from interference with this adhesive junction.